Time Domain Noise Filtering to Enhance Speech in Noise

DESCRIPTION (provided by the applicant): The Phase I study demonstrated that combining a directional microphone with a new noise processing method resulted in SIN improvements on the order of 10 dB as compared to an omni-directional microphone and no processing used in the same setting. Consequences for hearing impaired subjects with losses ranging from moderate to severe was to restore their performances to be statistically equivalent to that measured in quiet. Even more powerful was that for three out of four of the subjects evaluated using the best realization of the method, performances were numerically equivalent in both noise and quiet where the original SIN was 0 dB. The processing method is called Time Domain Noise Filtering (TDNF) and has been granted a US Patent. During this Phase II work we will implement the method in digital technology using a Digital Signal Processor (DSP) to make it compatible with digital hearing aid technology. At the same time, the greater flexibility of DSP technology, as compared to the analog methods used in the Phase I work, will be exploited to make the method adaptable to changing noise levels and to explore the dynamics of the method that might improve its performance even more. We will study a range of hearing impaired subjects including cochlear implant users. We have contacted both a hearing aid company and a cochlear implant company regarding use of the TDNF method in their devices. Letters from the companies are included in this application. PROPOSED COMMERCIAL APPLICATION: Not Available